Novel Treatment Targets For Affective Disorders Through Cross-Species Investigation of Approach/Avoidance Decision Making

PROJECT SUMMARY (Overall)
Major depressive disorder (MDD) and anxiety disorders are major public health problems characterized by
blunted approach-related behaviors and increased avoidance, which predict worse disease trajectories,
increased suicide risk, and poor treatment response. Despite this compelling evidence, little is known about the
neurobiological mechanisms underlying abnormal approach-avoidance behavior in these disorders, which has
hampered treatment development. To address this unmet need, we propose an integrated research program
through a unified Conte Center that will investigate the role of cortico-striatal-midbrain and nociceptin circuitry
in approach-avoidance behaviors. The goals will be to identify novel treatment targets and markers that map
disease course. These goals will be achieved by bringing together a highly interdisciplinary team with
complementary expertise and an established record of successful collaboration. The team will tackle pivotal
questions through a highly coordinated approach that will entail numerous conceptual and technological
innovations. Guided by a large amount of preliminary data, the proposed approach spans different species
(mice, non-human primates, humans), approaches (non-invasive neuroimaging, intracortical recordings and
deep brain stimulation in humans; optogenetics, chemogenetics techniques, and CRISPR-cas9 knockdown in
non-human animals), and units of analyses (genes, molecules, cells, circuits, physiology, behavior, self-report).
Critically, to increase translational impact, functionally identical tasks will be used and identical molecular
targets will be probed across three species. The Computational Modeling Core will test whether specific
states (e.g., MDD, anxiety, stress-induced depressive phenotypes) or pharmacological manipulations (e.g.,
nociceptin receptor antagonists) have similar effects on model parameters across species, which is expected
to improve the likelihood of successful translation. The unifying hypotheses are that: (1) MDD, anxiety
disorders are characterized by negative biases in approach/avoidance behaviors; (2) Negative biases in
approach/avoidance behaviors are linked to dysfunction in cortico-striatal-midbrain circuitry and nociceptin
system upregulation; and (3) nociceptin receptor antagonists and modulation of cortico-striatal-midbrain
circuitry will normalize approach/avoidance behaviors. These innovative hypotheses will be pursued through
four closely intertwined Projects supported by an Administrative Core and a Computational Modeling
Core. This unified research program will make unique contributions towards three NIMH Strategic Objectives:
(1) A better understanding of the pathophysiology of mental illness (NIMH Strategic Objective 1.1); (2)
Identification of novel treatment targets (Strategic Objective 3.1); and (3) Identification of markers that map
disease course (Strategic Objective 2.2). Thus, the significance and impact of the knowledge generated by
the Center will be substantial, as we aim to transform our understanding of the pathophysiology of two
disorders that affect >35% of the US population, which is a necessary step towards more effective treatments.

Public health relevance
Project Narrative Depression and anxiety disorders are major public health problems but our understanding of and treatment for these prevalent disorders remain lacking. To address these unmet needs, we propose an integrated research program through a unified Conte Center that will investigate the role of cortico-striatal-midbrain and nociceptin circuitry in approach-avoidance behaviors and in the pathophysiology of depression and anxiety disorders, towards the goals of identifying (1) novel treatment targets and (2) markers that map disease course. This will be achieved by bringing together a highly interdisciplinary team with complementary expertise and an established track record of successful collaborations, and who will be tackle these scientific challenges through experiments across species (mice, non-human primates, and humans) and units of analyses (genes, molecule, cells, circuits, physiology, behavior, and self-report).